RNCP WIDE DOSIMETRY GUIDANCE & MONITORING OF SOURCES, AND IRRADIATION PROTOCOLS

The purpose of this contract is to define a program-led strategy for the services, facilities, expertise and capabilities to develop a centralized dosimetry harmonization effort that fits the resources and circumstances of projects funded by the Radiation and Nuclear Countermeasures Program.